THE INTEGRATED DATA ACQUISITION CORE (IDAC)

ABSTRACT FOR IDAC
The Integrated Data Acquisition Core (IDAC) of the Aging Adult Brain Connectome (AABC) project will acquire
high-quality longitudinal data in the lifespan HCP-Aging (HCP-A) cohort, with the goal of studying vulnerability
and resilience in aging. The data will support the discovery of inflection points in aging and how those relate to
established biomarkers of risk/resilience for Alzheimer’s Disease (AD) or other AD related dementias (ADRD).
We will use the HCP acquisition model and build off the multi-site consortium of the HCP-A study, which has
acquired neuroimaging and extensive non-imaging phenotyping data from a large cross-sectional and
longitudinal sample of typical aging adults. The focus on vulnerability and resilience in the AABC project will
potentiate the HCP-A with an unparalleled dataset with up to 10 years of longitudinal data per individual, sampled
across the full aging spectrum for 1000 participants. This comprehensive dataset has great potential to uncover
early markers and behaviors that are associated with an increased risk for AD/ADRD. To accomplish this goal,
the IDAC will extend and oversee multi-site longitudinal collection of neuroimaging data (at 3T), behavioral,
neurocognitive, lifestyle and other non-imaging data, and biological samples from previous participants in the
HCP-A. The continuity of this dataset with HCP-A will allow for rich longitudinal characterization of major factors
relevant to general health and brain aging, including brain morphometry, structural and functional connectomics,
cognition, memory, genetic status, systemic health, lifestyle, and hormonal status. Pertinent to the goals of the
Projects we will collect new data on stress, social/community engagement, and adversity, with enhanced
recruitment of under-represented groups. Objective measures of sleep quality and physical activity using state-
of-the-art wearable technology are also added. Finally, high field (7T) magnetic resonance spectroscopy (MRS)
acquisitions (on clinical scanners) will be added at two sites, to support innovative Project hypotheses regarding
neurochemical changes across the lifespan and how they might correlate with other AD/ADRD risk factors. Our
specific aims are to: (1) implement and oversee harmonized 3T MRI data acquisition across the four sites at two
longitudinal time points (~2 years apart) in ‘typically-aging’ individuals aged 36-100+ years old, representative of
sex, race and ethnicity, and socio-economic status of the US; (2) implement and oversee 7T MRS for
neurochemical profiling; and (3) ensure proper collection of neuropsychological, behavioral, physiological and
lifestyle data, and biological samples across the four sites. The IDAC will work closely with all other aspects of
the AABC – including its four interconnected Projects, the Administrative Core, the Informatics, Data Analysis,
and Statistics Core (IDASC), and the Genetics and Multi-omics Specimens Core (GMSC) – to ensure consistent
data acquisition across time and sites, thus reducing the impact of protocol drift and site-specific variance.
Altogether, the IDAC will provide the foundational data for the Projects’ investigations of vulnerability and
resilience in the AABC and how the lifespan trajectory of various measures relates to risk factors for AD/ADRD.

Public health relevance
NARRATIVE FOR IDAC The Integrated Data Acquisition Core will be responsible for the collection of all the neuroimaging, cognitive, behavioral, physiological, lifestyle, and biospecimen data of the Aging Adult Brain Connectome (AABC). We will use our extensive experience with the Human Connectome Project and other multi-site studies to supply the AABC with the high-quality longitudinal data needed to study vulnerability and resilience in aging, with the goal of better understanding key inflection points in aging and their relationship to risk factors for Alzheimer’s Disease (AD) and AD related dementias.